Biostatistics and Bioinformatics Shared Resource

ABSTRACT
Overview: The University of Colorado Cancer Center (UCCC) Biostatistics and Bioinformatics Shared Resource
(BBSR) supports UCCC members and other Shared Resources (SRs) by providing biostatistical and
bioinformatic expertise and services for laboratory-based research, experimental therapeutic studies, population
sciences research, and clinical trials. Services: The BBSR provides biostatistical and bioinformatics support at
all stages of projects. Pre-study assistance includes study design, sample-size calculations, and
statistical/bioinformatic planning as needed for grant and clinical trial development. The BBSR also provides
consultation and safety monitoring of clinical trials. Data analysis is provided in the form of statistical
methodologies, interactive data analysis software, and assistance in preparing manuscripts and follow-up grant
applications. The BBSR participates in the Protocol Review and Monitoring System (PRMS) and Data and Safety
Monitoring Committees (DSMC). Expertise: The BBSR is comprised of 8 PhD-, 4 Master's-, and 2 Bachelor's-
level researchers who collectively offer substantial expertise in clinical trial design and analysis, longitudinal data
analyses, confounder adjustment, multi-omic data analysis, software development, predictive modeling, and
cancer-focused bioinformatics. Management: The BBSR is comprised of two equal, collaborative, but distinct
components – biostatistics and bioinformatics. Both are financially managed by the UCCC and overseen by the
Associate Director of Basic Research, H Ford. Use of Services: Since 2016, the BBSR has worked with 236
investigators. UCCC members representing all 4 programs account for ~85% of the total effort for the period and
resulted in 136 publications, 28% of which have an IF>10; and 38 funded grants. Operating Budget: CCSG
support represents 39% of the annual budget, with the remainder from direct grant support for BBSR staff (16%),
chargebacks (17%) and institutional funds (28%). Innovation and Development: The BBSR has contributed to
UCCC members' research through development of interactive analysis platforms that researchers use to explore
their own large datasets. These platforms have been heavily utilized by UCCC members (7472 analysis hours
in FY2020). BBSR is also developing data analysis tools to assist other SRs and their users. Consultation and
Education: The BBSR contributes to UCCC members' research by conducting one-on-one training and hosting
a monthly seminar series focused on bridging gaps between experimental wet lab research, new technologies
(e.g. MIBI, single cell sequencing), and the biostatistical and bioinformatic analysis methods for associated data.
Future Directions: The landscape in cancer research is continually changing with new technologies (e.g.,
multispectral, spatial imaging) and methodology (e.g., adaptive clinical trial design) being developed to advance
our basic and clinical understanding of cancer. Bioinformatics and biostatistics are critical to this increasing shift
to data-driven and digital research. To accommodate future growth in this space, the BBSR will acquire expertise
in needed areas through targeted training and hiring of new staff to align with the UCCC Strategic Plan.